Human-Machine Collaborations to Improve Prognosis and Clinical Decision-Making in Advanced Cancer

PROJECT SUMMARY/ABSTRACT
Advance care planning and palliative care represent evidence-based, high-quality care for patients with
advanced cancer. Early identification of patients at risk of short-term mortality is a promising strategy to
increase advance care planning and palliative care. However, this is limited by prognostic inaccuracy among
oncology clinicians, who overestimate prognosis for 70% of their patients with advanced cancer. While recent
advances in electronic health record (EHR) infrastructure and machine learning (ML) have allowed accurate
identification of patient' mortality risk, there is a fundamental gap in understanding how to integrate ML
prognostic algorithms alongside clinician intuition (“human-machine collaborations”) in the routine care of
patients with cancer. Dr. Parikh's research objective is to develop and test human-machine collaborative
systems that leverage ML algorithms to improve clinicians' prognostic accuracy in order to prompt earlier
advance care planning and palliative care among patients with advanced cancer. In prior work, Dr. Parikh has
prospectively validated and embedded into the EHR an automated ML algorithm to predict short-term mortality
risk among patients with cancer. In this application, Dr. Parikh proposes to take a fundamental next step in this
work by exploring strategies to improve prognostic accuracy and decision-making among oncologists treating
patients with advanced cancer. In Aim 1, Dr. Parikh will retrain and validate the existing ML mortality risk
prediction algorithm by integrating recently-available patient-generated health data. In Aim 2, Dr.
develop
prognostic
that
Parikh will
a vignette-based survey to assess optimal strategies of presenting ML predictions to improve
accuracy. He will administer this survey to a large national sample of medical oncologists to ensure
clinician perspectives are incorporated into interventions.In Aim 3, Dr. Parikh will develop two models of
human-machine collaborative systems to generate real-time mortality estimates that integrate clinician and
algorithm predictions. In a pragmatic multi-institutional clinical trial among patients with advanced cancer, Dr.
Parikh will test the impact of human-machine collaborations on prognostic accuracy and rates of advanced
care planning and palliative care referral. These findings will have important implications for patients with
cancer, their caregivers, oncology clinicians, and health systems. More broadly, the methods proposed may
serve as a blueprint to develop and evaluate human-machine collaborations in oncology. This
facilitate
judgment
highly-qualified
Dr.
development
improving
research will
t raining in areas vital to Dr. Parikh's career goals: dvanced predictive modeling, survey methods and
and decision-making, human-machine interfaces, and pragmatic clinical trials. Dr. Parikh has two
and committed mentors: Dr. Justin Bekelman, an expert i n cancer care delivery r esearch, and
Jinbo Chen, an expert in EHR-based predictive model development. The proposed research and career
plan will enable Dr. Parikh to transition to an independent physician-scientist devoted to
the quality and applicability of predictive analytics in the care of patients with cancer.
a

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because we aim to improve prognostication for patients with advanced cancer by developing frameworks to integrate clinician intuition with machine learning algorithm- based mortality risk predictions (“human-machine collaborations”), a critical step to better identify patients who may benefit from earlier advance care planning and palliative care. This research proposal will optimize an existing machine learning mortality risk prediction algorithm and methodologically assess strategies to present machine learning estimates to clinicians in order to increase prognostic accuracy, advance care planning, and palliative care among patients with advanced cancer. The project is relevant to the NCI's mission by generating fundamental knowledge to inform clinicians, researchers, and policymakers about effective methods to improve and integrate predictive algorithms into clinical practice, thereby allowing better targeting of evidence-based interventions to improve quality of life for patients with advanced cancer.